Northwestern University Lead Academic Participating Site - Revision -5S2

Summary/Abstract:
The Robert H. Lurie Comprehensive Cancer Center of Northwestern University (LCC) has a long history of NCTN
participation with ECOG membership since 1973. Currently, the LCC infrastructure supports participation in
clinical trials and ancillary studies through the ECOG-ACRIN, SWOG, Alliance, NRG, and COG. LCC has an
established history of accruing to and participating in NCTN trials including selection as a high performing site in
2015, 2016 and 2017.
In 2019, Northwestern University was designated as a Lead Academic Performing site (LAPS) and in this new
role continues to significantly accrue patients to NCTN trials, exceeding planned accrual goals in both years as
a LAPS institution.
Through continued demonstration of significant scientific accomplishments and new initiatives, recruitment of
accomplished senior faculty and productive junior faculty, comprehensive and integrated infrastructure for
oversight of cancer-related clinical trials, LCC will continue to expand participation in NCTN trials, provide
scientific leadership of key network activities, and increase inter-institutional collaborations and access to unique
scientific resources, to advance cancer interventions.

Public health relevance
Narrative Home for exceptional science and of internationally renowned cancer experts and supported by a comprehensive clinical research infrastructure, the Robert H. Lurie Comprehensive Cancer Center of Northwestern University (LCC) is will continue leadership of and participation in NCTN trials as a high performing LAPS, recruiting patients in the Chicago metropolitan area to trials aiming to improve the lives of people with cancer.